Targeting galectin-3 to intervene COVID-19

Project Summary/Abstract
The COVID-19, caused by the severe acute respiratory syndrome coronavirus 2 (SARSCoV-2), is a global
pandemic with catastrophic consequences for healthcare systems and populations. The increased morbidity
and mortality in older persons and those with diabetes (12-22%) and hypertension (23.7-30%) is particularly
concerning due to high incidence of diabetes throughout the world. The angiotensin-converting enzyme 2
(ACE2) receptor serves as a high affinity receptor for SARSCoV-2 to enter the lungs. Interestingly, patients
with diabetes, who are treated with ACE inhibitor and angiotensin II type-I receptor blocker, highly express
ACE2 making them more susceptible to COVID-19. For infection and pathogenesis, virus needs to attach and
penetrate a thick glycan rich mucus and glycocalyx before binding its entry-receptor and galectin-3 (Gal3) is
believed to play a role in the enhanced attachment of SARSCoV-2 through binding to the spike glycoprotein.
Gal3 promotes viral infections and enhances of pro-inflammatory cytokines such as interleukin (IL)-6, tumor
necrosis factor (TNF)-α. We confirmed Gal3 binding to SARSCoV-2 spike glycoprotein. Interestingly, increased
levels of Gal3 are associated with prediabetes, diabetes, and hypertension. Gal3 binds also directly to the
insulin receptor (IR) and inhibits downstream IR signaling promoting obesity-mediated inflammation
(macrophage-derived Gal3) and insulin resistance in type 2 diabetes (T2D). These fundamental observations
elucidate a novel role of Gal3 that promotes viral infection and uncontrolled release of pro-inflammatory/anti-
inflammatory cytokines and suggest that specific inhibition of Gal3 may represent a promising therapeutic
strategy not only treat COVID-19, but also COVID-19 impacted diabetic patients.
Our scientific premise is that we have developed a very potent Gal3 antagonist, named TFD100, from a
natural dietary source (PNAS publication PMID: 23479624). In our preliminary studies, TFD100 inhibited
replication of SARSCoV-2. TFD100 reversed Gal3 mediated inhibition of IR activation. TFD100 also decreased
fasting glucose and improved glucose tolerance and insulin sensitivity. Here, we propose to investigate the
therapeutic utilities of TFD100 for treating COVID-19 and COVID-19 impacted T2D in a relevant COVID-19
“humanized” mouse model (human ACE-2 transgenic mice). Following drug treatment of SARSCoV-2 infected
mice, viral load (primary endpoint) and resolution of dysregulated inflammation (secondary endpoint) will be
measured. To investigate TFD100’s ability to intervene COVID-19 impacted T2D in hACE-2 mice, obese-
induced T2D will be made first in these mice with high fat diet followed by SARSCoV-2 infection. Following
drug treatment, glucose and insulin tolerance as well as viral load (primary endpoints) will be measured. For
other endpoints, resolution of host-response as dysregulated inflammation (cytokine storm) and restoration of
insulin signaling will be measured by the frequency of pro-inflammatory/anti-inflammatory biomarkers (Gal3,
ACE-2, and other proteins) in blood, lung, liver, fat, and muscle. This also includes determination of changes in
pro/anti-inflammatory immune cell frequencies denoted by polarization of macrophages and helper-T (Th)
cells. Gal3 inhibition is anticipated to be a significant advancement in the arsenal against SARSCoV-2
impacted T2D, and possibly SARSCoV-2 infection as an antiviral therapy.

Public health relevance
Project Narrative Galectin-3 (Gal3) not only promotes insulin resistance of type 2 diabetes (T2D), but also is involved in the viral attachment and cytokine storm. The objective of this project is to use Gal3 antagonist to treat COVID-19 and COVID-19 impacted T2D.